PRAISE AMLODIPINE EFFECTS MORTALITY AND MORBIDITY IN HEART DISEASE

A previous study demonstrated that amlodipine improved exercise duration compared with placebo and was safely administered in the presence of digoxin, diuretics, and angiotensin converting enzyme inhibitors to patients with heart failure. The purpose of this study is to confirm the results of that previous study and assess the efficacy and safety of amlodipine versus placebo.